The role of fathers' sleep quality and white matter microstructure on the adjustment to parenthood

PROJECT SUMMARY/ABSTRACT
The transition to parenthood is a period of profound transformation and often vulnerability in new
parents. Though most of the research on this transition has focused on mothers, new fathers must also adapt
to parenthood. Many parents experience sleep deprivation and poor sleep quality, which may increase mental
health risks of new parents and reduce the quality of caregiving behavior. Prior work in non-parent samples
suggests that sleep quality may be linked to the structural connectivity of the brain, as measured within white
matter microstructure (WMM). Less efficient connectivity of WMM has also been associated with mental health
problems. This project will examine postpartum sleep quality in first-time fathers and test associations with their
postpartum mental health and WMM. The project also examines postpartum WMM as a mediator between
sleep quality and mental health symptoms during the transition to parenthood. This project draws from an
existing longitudinal study of first-time parents followed from the prenatal to postpartum periods that
incorporated neuroimaging.
Study aims are to: (1) Examine how postpartum sleep quality, controlling for prenatal sleep quality,
affects psychological adjustment to parenthood in new fathers; (2) Investigate whether sleep quality is
associated with postpartum white matter microstructure (WMM) among first-time fathers; (3) Examine the
mediating role of postpartum WMM on the relationship between postpartum sleep quality and fathers’
adjustment to parenthood. Study findings can provide insight into the role of sleep on the paternal brain and
mental health and inform interventions facilitating the adjustment to parenthood. The proposed project will
support the applicant’s training in biobehavioral research methods to become an interdisciplinary health and
family studies researcher.

Public health relevance
PROJECT NARRATIVE Parents may struggle to adjust to first-time parenthood, but the mechanisms underlying parents’ mental health symptoms during this period are not well understood. Though sleep quality is associated with mental health symptoms and white matter microstructure (WMM), no study has examined the role of sleep quality on parents’ mental health symptoms and WMM during the transition to parenthood. The proposed study examines sleep quality in new fathers at six months postpartum and tests associations with their WMM and mental health symptoms at one year postpartum, with the goal of identifying modifiable policy and practice targets to support parents’ adjustment to parenthood.